University of Washington Health Services Research Training Program

PROJECT SUMMARY/ABSTRACT
Objective. The University of Washington (UW) Health Services Research Training Program provides
predoctoral research training to individuals interested in careers in health services, behavioral, and clinical
research that are relevant to AHRQ's mission. The Program supports AHRQ's efforts to expand and diversify
the scientific workforce engaged in research to improve clinical and health systems' practices. The Program
builds capacity in health services research nationally and in the Pacific Northwest region.
Trainees. The Training Program supports ten predoctoral trainees per year: eight receiving broad-based
training in health services research through the Health Services doctoral program and two receiving focused
training in health outcomes, economic outcomes, and policy research on health care technologies through the
Health Economics and Outcomes Research doctoral program. Trainees receive two years of support, typically
upon entry into one of the doctoral programs. Trainees with diverse backgrounds are recruited for their
potential to make a successful career in health services research.
Design. Trainees obtain either a PhD in Health Services or a PhD in Health Economics and Outcomes
Research. The Health Services doctoral program offers a competency-based curriculum that provides: 1)
comprehensive knowledge of the health care system, health policy, and the determinants of and disparities in
population health; 2) rigorous training in the theory and research methods of core health services research
disciplines; disciplines; 3) expertise in an area of emphasis through intensive preparation in theory, content,
and methods; and 4) training in effective communication within organizations and with scientific and lay
audiences. The Health Economics and Outcomes Research doctoral program offers a competency-based
curriculum that prepares trainees to compare the clinical, economic, and patient-centered effects of medicines
and other health technology in patient populations and conduct patient-centered outcomes research. Trainees
in both doctoral programs conduct applied, multidisciplinary research at UW research centers or external
research partners. Strong mentorship produces high quality research aligned with AHRQ's mission and priority
populations to facilitate the translation of findings into policy and practice.
Outcomes. The Training Program has an excellent record of producing well prepared, productive health
services researchers. Of the 35 predoctoral trainees who graduated with a PhD, 31 are employed in research
positions in universities or other research organizations. The 35 graduated trainees and 20 current trainees
published 118 papers between doctoral program entry and graduation.

Public health relevance
The research that trainees completing the UW Health Services Research Training Program will conduct will further AHRQ's mission to make health care safer, higher quality, affordable, accessible and equitable.